Evaluation of APA’s ACT Program: Engaging Fathers to Prevent Adverse Childhood Experiences

Project Summary
This proposed study addresses Objective #3 of RFA-CE-21-004, “Effectiveness research to evaluate primary
prevention strategies that incorporate a dual-generation approach for caregivers and their children that breaks
the cycle of violence and adversity”. Child maltreatment (CM), a form of violence exposure most often
perpetrated by caretakers, is a serious public health issue that results in health inequity across the lifespan and
predisposes youth to violence perpetration. There is increasing evidence for early intervention efforts targeting
child maltreatment prevention via parent training programs. However, major limitations of this research involve
the paucity of male caregivers included in outcome evaluations and the failure to look at other associated
violence outcomes. In particular, exposure to adult intimate partner violence (IPV), which frequently co-occurs
in families with CM, has the same adverse behavioral and health outcomes for youth including youth violence
(YV). Given the significant number of shared risk and protective factors among CM, IPV, and YV, there are
reasons to suspect that efficacious CM prevention programs will prevent these multiple forms of violence. The
purpose of this proposed study is to explore this potential in an evidence-based, parent training program for
CM prevention, ACT Raising Safe Kids. This project builds on domestic on international evaluations of the ACT
program by implementing a rigorous quasi-experimental design with male caregivers. For the proposed project,
500 male caregivers will be recruited from 4 service provider sites that provide an armamentarium of services
to families, including the ACT program. Inverse probability of treatment weighting will be used to balance the
intervention group and the control group on potential confounding covariates. Assessments will be collected at
baseline, 10 weeks (i.e., immediately post-intervention), 6 months post-intervention, and 12 months post-
intervention. Outcome measures include CM perpetration risk, IPV, and youth aggression (a risk factor for
more severe forms of YV in adolescence). Additionally, we will assess a number of mediating variables
including parenting behaviors, parental stress, family conflict, and anger regulation. For the final primary AIM,
we will also collect cost diary data from ACT participants, facilitators, and administrators so we may a cost-
utility analysis. Data collection will be web-based via caregiver report. It is hypothesized that male caregivers in
the ACT condition will report less CM risk, IPV, and YV risk over time. This research is innovative as it has
potential to demonstrate the ability of a single program to eliminate risk for multiple forms of violence typically
addressed not only by different programs, but in different silos of the scientific literature. Such findings could
have substantial public health impact providing evidence for the consolidation of resources to, and broad
dissemination of, single cross-cutting prevention programs. Given that, ACT is currently implemented in 13
countries and 80 U.S. communities, the public health impact would be substantial.

Public health relevance
Project Narrative The purpose of this project is to examine the impact of the child maltreatment prevention program ACT Raising Safe Kids on intimate partner violence by male caregivers and aggression by their children. We will additionally evaluate the cost-effectiveness of the program. Results favoring the prevention of these multiple forms of violence will establish the ability to develop a singular cost-effective program that influences multiple related health outcomes.